3-Dimensional virtual ventricles to design precision therapies in hypertrophic cardiomyopathy

Project Abstract
Hypertrophic cardiomyopathy (HCM) is the most common inherited cardiac disease worldwide and is the
leading cause of sudden cardiac death (SCD) in young people. Though HCM is characterized by more than 1400
mutations in the genes encoding the contractile apparatus of the cell, the pathophysiology of HCM encompasses
diverse clinical symptoms; it can eventually lead to heart failure and fatal ventricular arrhythmia. Despite nearly
5 decades of research, there is currently no disease-modifying or mortality-reducing drug therapy for HCM
patients. HCM treatment has failed for two key reasons: (1) arrhythmias are an emergent phenomena in space
and time: single cell markers of arrhythmia fail to predict the effects on the whole heart; and (2) HCM is markedly
heterogeneous - it is likely there are specific molecular underpinnings leading to differential drug efficacy that
are not appreciated in large clinical trials and preclude a “one-size-fits-all” approach.
I hypothesize that the key to understanding the therapeutic potential of drug therapy for HCM is through
patient-specific modeling of their cardiac electrophysiology and ventricular ultrastructure. Thus, the goal of this
research award is to merge clinical data, genetics, advanced imaging, and biophysical characterization
of HCM to understand how higher dimensional ultrastructural remodeling influences cellular
electrophysiology to design precision-targeted drug therapy. Specifically, I will develop a detailed
electrophysiologic model of HCM that recapitulates mutation-specific alterations to better understand key
determinants of success and failure for drug therapy. I will study patient-specific responses to two test drugs:
ranolazine and b-blockers by optical imaging of dissociated adult cardiomyocytes of patients with HCM. I will
then use multimodal imaging to characterize ventricular geometry and myofiber architecture of these patients to
create a 3D virtual ventricle to test our single cell drug predictions. These aims will allow us me understand the
bidirectional relationship between ventricular remodeling and single cell electrophysiology and drug therapy.
I believe I have the appropriate background and resources to address the knowledge gaps described but
require additional mentorship and training to transition to independence. I previously earned a PhD in
computational cardiology and have undertaken additional training in basic and translational cardiovascular
research. I have completed clinical training in Internal Medicine, Cardiology, Echocardiography, and Advanced
Heart Failure and Cardiac Transplant, and have been appointed Instructor of Medicine as of July 1, 2020. To
transition to an independent investigator, this K08 award will allow me to focus on developing new experimental
skillsets in cellular electrophysiology, optical imaging techniques, as well as cardiac MRI and echo
imaging that will compliment his computational background. At the conclusion of this award period, I will
have acquired the skills to become a leader in translational characterization of heart failure and cardiomyopathies
with the ultimate goal of designing novel therapies for patients suffering from these diseases.

Public health relevance
Project Narrative Hypertrophic cardiomyopathy is a highly prevalent inherited cardiac disorder that causes abnormal heart rhythms leading to sudden death, often in young people. Despite 5 decades of research, there are currently no disease modifying therapies. I propose to develop detailed computational models of the human ventricle with hypertrophic cardiomyopathy to design precision-targeted drug therapy.